Serological markers of natural immunity to Plasmodium falciparum infection

PROJECT SUMMARY
Plasmodium falciparum is the most common and deadly cause of malaria. An effective malaria vaccine has the
potential to make a pivotal change in malaria control and eradication. For a vaccine to contribute significantly to
malaria eradication, it must target the early, pre-erythrocytic part of the lifecycle to block both symptomatic
disease and asymptomatic infection, which perpetuates transmission. Naturally acquired immunity to pre-
erythrocytic infection is acquired with exposure but remains poorly understood and continues to impede vaccine
efforts. DeAnna Friedman-Klabanoff, M.D., a pediatric infectious disease specialist at the University of Maryland
School of Medicine, developed this career development award proposal to use novel high-throughput tools to
define naturally acquired humoral immunity to diverse pre-erythrocytic epitopes associated with protection, which
could lead to novel vaccine candidates. Dr. Friedman-Klabanoff’s long-term goal is to become an independent
clinical and translational researcher dedicated to the development of a malaria vaccine, applying immunology
and data science to inform and optimize vaccine development. To gain the skills necessary to achieve this goal,
Dr. Friedman-Klabanoff proposes a career development plan that includes mentoring from Drs. Miriam Laufer,
Shannon Takala Harrison, Michael Cummings, Andrea Berry, Kathleen Neuzil, and John Adams, leaders in the
fields of international research design and leadership, molecular epidemiology, data science for analysis of large
data sets, use of peptide microarrays to study malaria, vaccinology, and in vitro models of pre-erythrocytic
immunity. This project will utilize samples and data from a cohort study of malaria in Malawi led by Dr. Laufer,
the primary mentor for this proposal. Household members were followed monthly for detection of malaria
infection and mosquitoes were collected from the houses to identify bloodmeal sources. Bloodmeal sources will
be identified by matching the human DNA found in the mosquito bloodmeals to DNA from enrolled participants .
Mosquito salivary glands will also be tested for P. falciparum infection to determine if the mosquitoes were
infectious. Children will be defined as protected or infected based on whether they develop blood-stage infection
during the month after an infectious bite. Aim 1 of this proposal will be to identify serologic responses associated
with natural protection against P. falciparum infection after exposure to an infectious bite. Serum from the day of
exposure will be probed on a custom-developed peptide microarray designed from diverse, field-derived
sequences to characterize pre-exposure immunity to pre-erythrocytic antigens. Aim 2 of this proposal is to
assess the functional role of antibodies targeting P. falciparum pre-erythrocytic antigens of interest. B- and T-
cell epitope prediction tools will be used to find predicted epitopes in pre-erythrocytic proteins and their variants,
and in vitro liver models will be used to assess the functional role of antibodies to these epitopes to validate and
down select the potential epitopes. The practical implications of this work will be to identify promising epitopes
that are targets of protective immunity.

Public health relevance
PROJECT NARRATIVE Plasmodium falciparum, the most common species of malaria, kills more children than any other pathogen, and the development of a highly effective vaccine has been challenging. Children acquire immunity to malaria with repeated exposure, but the mechanism is poorly understood. We will collect samples from children who are exposed to Plasmodium-infected mosquito bites and compare the immune responses among those who develop infection to those who do not to identify possible targets for vaccines to prevent malaria infection.